SEMINARS GIVEN BY MICHAEL MACCOSS (2009 - 2010)

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. From discovery to targeted protein analy Integrating the workflow from traps to triples, Thermo Fisher Scientific United Kingdom User Meetings, Leeds and London, UK, 2009 First Impressions of New Ion Trap Technology: Implications and Impact for Proteomics, Thermo Fisher ASMS User Meeting, Philadelphia, PA, 2009 Complementary Proteomics Strategies for Understanding the C. elegan Genome, British Society for Proteome Research, Wellcome Trust Conference Center, Hinxton, Cambridge UK, 2009 Raising the Bar in Proteomics: Developing New Technologies to Keep up with Genomics, Lorne Proteomics Symposium, Lorne, Australia, 2010 Application of FAIMS-MS to Shotgun Proteomics, Pittcon Meeting, Orlando, Fl, 2010 Improving the Throughput, Reproducibility, and Usability of Proteomics Measurements, Fred Hutchinson Cancer Research Center, Seattle, WA, 2010 Facilitating Alternative Proteomics Data Acquisition Strategies by Improving the Data Analysis, CASB, San Diego, CA, 2010 Targeted Analysis of Complex Mixtures: A Computational Workflow from Discovery to Validation, Recomb-CP, San Diego, CA, 2010 Advances in the Analysis of Complex Protein Mixtures: Finding Protein Needles in Cellular Haystacks, Department of Biology, University of New Mexico, Albuquerque, NM, 2010 Improving the Throughput, Reproducibility, and Usability of Proteomics Measurements, Thermo/Pierce, Rockford, Il, 2010 Improving Shotgun Proteomics by Multiplexed MW Separation of Intact Proteins, Protein Discoveries User Meeting, ASMS, Salt Lake City Utah, 2010 Bridging the Gap from Discovery to Validation: Automating the Workflow for Establishing Multiplexed Targeted Mass Spectrometry Methods, Foundation of the National Institutes of Health, Biomarker Consortium, Bethesda, MD, 2010 Integrating new sample prep, instrumentation, and analysis tools to improve the characterization of complex protein mixtures, University of Gent, Belgium, 2010